Using System Dynamics Modeling to Foster Real-time Connections to Care

Project Summary
The two objectives of our currently funded HD2A Innovation Project are: (1) to implement a novel, scalable,
evidence-based, intervention (i.e., our telehealth platform RecoveryPad) that links people who have overdosed
with access to medication for opioid use disorder (MOUD), harm reduction services, and recovery supports,
and (2) to collect high-quality data about the processes and outcomes associated with deployment of this
platform that can be integrated with our existing system dynamics (SD) model to determine if, where, when,
and what interventions should be implemented in the future. In this manner, our data (i.e., input and output
from the SD model) drives our action (i.e., provision and refinement of RecoveryPad) in a continuous feedback
loop. This administrative supplement will allow integration of an ethical artificial intelligence (AI) framework into
the refinement and evaluation of the telehealth intervention of the parent project. Specifically, we will evaluate
datasets, model assumptions, algorithmic inputs, development, and performance of the parent project for
potential biases, particularly in relation to exacerbating disparity of OUD-related outcomes among vulnerable
populations. Through the systematic detection and mitigation of algorithmic biases, we will enhance the
fairness of AI-augmented interventions, promoting equitable treatment engagement across diverse
demographics. The insights we gain will not only optimize our own RecoveryPad platform and system
dynamics model but will also contribute to wider ethical AI applications in healthcare. Moreover, our work
stands to improve outcomes for individuals with OUD and support national efforts to address the opioid crisis.
Specifically, we propose the following supplemental aims: 1) Aim 1 - to assess bias and fairness within the SD
model: This aim seeks to translate AI fairness assessment methodologies into iterative refinement of the
existing system dynamics model. By leveraging our integrated team that includes a bioethicist, AI experts, data
scientists, clinicians, and people with lived experience, we will examine key model inputs and their potential
bias implications on model outputs for sensitive demographic attributes. Furthermore, we intend to ensure
representation and mitigate any algorithmic bias. 2) Aim 2 - to assess bias and overall fairness of
RecoveryPad: Aim 2a) Fairness evaluation of datasets and the brief negotiated interview (BNI) process during
RecoveryPad Development: We will assess potential biases by analyzing whether our population-level
machine learning algorithms exhibit differential predictions for MOUD engagement across diverse groups using
historical electronic health record data, where ED patients have received a BNI from an in-person health
promotion advocate. Aim 2b) Bias and Fairness Assessment of RecoveryPad: We will evaluate bias and
fairness within RecoveryPad through simulated and real-time participant conversational encounters, leveraging
existing frameworks for assessing conversational AI for bias and toxicity.

Public health relevance
Project Narrative Our team will offer individuals who have overdosed access to a telehealth platform that links them with providers who prescribe medication for opioid use disorder (MOUD) and will collect data about these linkages to enhance our ability to improve future OUD outcomes. We will use a data-driven model to help us determine how to best implement this telehealth platform and will apply artificial intelligence and machine learning techniques to minimize utilization of biased data in our model, in addition to assisting us in ensuring that biased data does not influence the public health recommendations that we make as result of this work.